ATG2 mediated lipid transport is essential for lipid droplet homeostasis

Project Summary/Abstract
Lipid droplets (LDs) are cellular energy reservoirs in the form of triglycerides and steryl esters and are central
to the maintenance of membrane structure and energy homeostasis. They serve as the primary organelle for
energy storage both in cells and in organisms (as adipose tissue). To regulate cellular and organismal
energetics, lipids must be trafficked to other organelles where they are consumed by fatty acid oxidation or
enzymatically altered to maintain membrane structure. Dysregulation of cellular lipid metabolism is a common
feature of metabolic disorders such as obesity, diabetes, nonalcoholic fatty liver disease (NAFLD), and
nonalcoholic steatohepatitis (NASH). The VPS13 or repeating beta groove (RBG) family of proteins- containing
ATG2A/B- comprises proteins thought to partake in pipe-like, bulk lipid transport between two membranes.
Deletion of ATG2 and two of its known binding partners lead to massive accumulation of LDs, defects in
lipoprotein biogenesis, and full-blown NASH. ATG2 localizes primarily to LDs, and our group has recently
demonstrated that the protein can facilitate bulk lipid transfer in vitro. Loss of ATG2 blocks fluorescent fatty
acid movement from the LD to mitochondria through yet undefined mechanisms. However, whether ATG2
directly participates in lipid transport at the LD and how other organelles and protein machinery partake in this
process is not known. In this proposal, I outline a strategy to directly test ATG2 mediated lipid transport at the
LD, identify the membranes that participate in lipid transport at the LD, and mechanistically define the proteins
that cooperate in lipid transport.
This project is structured to maximize progress toward my training goals in in vitro biochemistry, assay design,
and quantitative image analysis, thereby equipping me with a full set of technical and intellectual skills to
generate mechanistic explanations to complex biological questions. Accordingly, I place a strong focus on in
vitro biochemistry, cell-based assays, and automated image analysis. In aim 1, I draw heavily on the expertise
of the Melia and Reinisch labs to directly test for lipid transport activity of ATG2 at the LD using a combination
of newly published and newly engineered in vitro lipid transport assays and cell-based assays of LD
accumulation. In aim 2, I build on an APEX proximity labeling approach validated in the Melia lab to identify
proteins and membranes that ATG2 links to the LD. In aim 3, I employ a wide range of cell-based assays,
binding assays, and automated image analysis to determine which proteins mechanistically cooperate with
ATG2 to move lipids at the LD. This project will pioneer new approaches to test lipid transport in VPS13/RBG
family proteins and it will elucidate novel mechanisms of lipid transfer at the LD.

Public health relevance
Project Narrative Lipid droplets are central to regulating intracellular energy availability. The lipid transport protein ATG2 is known to regulate lipid droplet homeostasis, and its interactors are known to regulate lipid droplet homeostasis and lipoprotein formation. This project seeks to mechanistically determine how ATG2, and its interactors regulate lipid droplet homeostasis in cells.